Research Measures Method and Data Management Core

SUMMARY – RESEARCH METHODS, MEASURES, AND DATA MANAGEMENT CORE
The Research Methods, Measures, and Data Management (RMMDM) Core of the proposed Massachusetts
Partnership for Community-Engaged Cancer Control Equity (Mass PCECCE) will acquire and integrate
data from multiple sources and on multiple levels of influence, anchored in the Center's guiding conceptual
frameworks. Specifically, we will implement a robust Data Ecosystem for the Center that will include all
research, clinical, organizational, and community-level data collected as part of the Center. The Data
Ecosystem will be designed to create efficiencies for the Community Gateway to Health Equity Study, our
social determinants of health (SDOH) research project, the Community Responsive Projects Program, the
Administrative Core, and our partner community health centers (CHCs) by centralizing the acquisition,
processing, and management of outcomes data across projects; sharing de-identified data with investigators;
and overseeing data reporting to federal agencies and community partners. This approach also enables data
collected by one project (e.g. community-level structural stigma) to easily be used by other projects. All data
resources are available to all research teams in the Center to maximize efficiency, but most importantly to
maximize learning that will benefit participating communities. We will also achieve efficiencies as well as
standardization by centralizing as much data collection as possible. For example, the Research Engagement
Survey Tool will be administered centrally to all community partners who are collaborating with the Center to
assess the quality of our community engagement processes. Although each research team could collect this
data independently, centralizing this function is efficient and allows us to more easily look at our performance
overall as well as for individual projects.
The RMMDM Core will be co-led by Dr. Daniel Gundersen (survey methodologist) and MPI Dr. Cheryl Clark
(community located health equity/SDOH researcher), who have outstanding and complementary skill sets.
The overall goal of the RMMDM Core is to facilitate Center productivity by eliminating redundancies in data
collection, analyses, and evaluation across projects, and to maximize the impact of our work. The Core has
also been designed to catalyze the formation of a research methods infrastructure at our community partner,
the Institute for Health Equity Research, Evaluation, and Policy (IHE), which Dr. Clark leads.
The work of the RMMDM Core will directly support both the SDOH research project and the initial Community
Responsive Projects Program (CRP) Project, which will use centrally collected data and the Core's
methodological and statistical resources, and will oversee the CRP Program overall. Building on our Data
Ecosystem, the Core is well-positioned to support data sharing across the U19 Consortium, as well as
consortium-wide pilots that utilize our data and strong partnership infrastructure.